VISION RESEARCH CENTER

The objectives of the Vision Research Center grant are: (1) to increase knowledge concerning normal vision; (2) to apply this knowledge to the preservation and restoration of human vision. To achieve these overall scientific goals, a multidisciplinary research program has been developed. Related to the eye and vision, this program consists of the following major basic science and clinical research components: Molecular Biology, Biophysics, Electrophysiology, Microbiology and Immunology, Ophthalmic Pathology, Ophthalmology--Retina and Lens Disease Research, Pediatric Ophthalmology Research and Vision-Related Genetic Disorders. Appropriately interrelated, the major components of this program apply a wide spectrum of laboratory and clinical methods of investigAtion to an extensive array of research projects. Support is requested for the following Core modules: Biochemistry, Pathology, Electron Microscopy, Machine Shop, Clinical Investigation, and Administration.